IGF::OT::IGF PURPOSE TO AWARD THE TASK ORDER ENTITLED "WHOLE BODY PLETHYSMOGRAPHY IN RATS" PERIOD OF PERFORMANCE MARCH 3, 2019 TO MARCH 4, 2020 NIDA REF. NO. N01DA-18-8939

Toxicological Evaluations of Potential Medications